Yki-Mitf-ECM regulation of eye progenitor epithelium morphology.

Project Summary:
Form is inextricably linked with function in the eye, where the topology of the retina in part determines what
incident light can be detected; this is true for both the camera eye of vertebrates and for the compound eyes of
invertebrates, such as the fly, Drosophila melanogaster. In both cases, retinal development and function is
promoted through its association with a support tissue – retinal pigmented epithelium (RPE, vertebrates) or
peripodial epithelium (PE, fly). While much study has been focused on the molecular mechanisms underlying
retinal specification, photoreceptor differentiation and on vision-associated diseases, the contribution of
support tissues to the development and morphogenesis of the adult eye structure has received significantly
less attention. Mutations in YAP1 and MITF are associated with congenital malformation of the human eye,
resulting in the optic fissure closure defect coloboma (YAP1 and MITF) or microphthalmia (MITF). In neither
context are the factors or processes upstream or downstream of YAP1 or MITF known or understood. I have
recently described a Retinal Displacement (RDis) paradigm in fly, where developmental misalignment of Retina
and PE tissues leads to congenital malformation of the compound eye. This powerful genetic model has led us
to identify the conserved fly orthologs of YAP1 (Yki) and MITF (Mitf) as critical regulators of ocular epithelial
topology. Furthermore, this model has allowed us to discover how the Hippo signaling cascade regulates Yki in
the developing eye. Our preliminary data suggest that another critical factor in fly eye morphogenesis is the
attachment of support tissue cells to the extracellular matrix (ECM), and recent work in vertebrate models has
highlighted the importance of ECM in maintaining the Retina-RPE tissue boundary. The proposed research will
explore the relationships among ECM, Yki and Mitf, in the genetically tractable fly model. In Aim 1 of this
proposal, we will perform the first systematic investigation into how ECM factors contribute to ocular tissue
morphogenesis, and we will investigate how ECM and PE-ECM connectivity are disrupted in RDis. In Aim 2,
we will uncover the transcriptional targets of Yki and Mitf in the developing eye and test the hypothesis that
they directly regulate ECM factor expression to maintain ocular epithelium topology. Our enhanced
understanding of PE-ECM attachment and its molecular regulation will serve as a springboard for future
detailed studies of the interplay among cell and epithelial properties that control eye organogenesis.

Public health relevance
Narrative: Yki, Mitf and the ECM play essential roles in maintaining the overall architecture of the developing ocular epithelium in the fly. Here we develop this model to investigate how ECM deposition and attachment contribute to organ morphogenesis, and to better understand the roles of Yki (YAP1) and Mitf (MITF) in regulating ECM factors and epithelial architecture.